Prefrontal-Accumbens Neurocircuits Mediating Response to Social Stress

PROJECT SUMMARY
(FOR EQUIPMENT SUPPLEMENT)
Mal-adaptations to stress often leads to impaired social behavior, a shared domain across many
neuropsychiatric conditions. While it is well-established that environmental factors, such as stress, play an
etiology role, the brain mechanisms, particularly the role of specific neural circuits mediating the maladaptive
responses, remain to be elucidated. Chronic social defeat stress (cSDS) in mice is a highly relevant, validated
model to study brain circuit mechanisms related to stress. cSDS has been shown to induce morphological and
functional changes in multiple brain regions including the medial prefrontal cortex (mPFC), which contains
heterogeneous cell types and is interconnected with other limbic brain regions. Using recently developed
neuronal activity reporter mouse lines, termed fosTRAP and TRAP2, the applicants’ laboratories have
determined that acute (aSDS) and chronic (cSDS) social defeat stress activate distinct populations of
projection neurons in the mPFC. The goal of this study is to determine whether specific circuit connectivity is
pertinent to stress-induced social impairment and if novel therapeutic intervention strategies could be devised
to selectively target the relevant circuits to combat the social deficits and alleviate off target effects. The
expertise of two laboratories (Ferguson- mouse behavior, molecular biology and bioinformatics; Qiu-
neurophysiology and functional circuit mapping, optogenetics) will be combined to test the hypothesis that
cSDS-induced, impaired social behaviors are encoded within a specific neural circuit in the mPFC. The PIs will
employ a TRAP2 reporter mouse line to gain genetic access to the mPFC neurons that are activated by cSDS,
followed by investigation of: Aim 1) whether disrupted synaptic homeostasis selectively occurs in NAc-
projecting mPFC neuronal populations that are activated by the cSDS, and whether disrupted synaptic
homeostasis occurs selectively in the mice susceptible to social impairment. In Aim 2, this team will use
targeted optogenetic manipulation of neural activity in the cSDS-activated mPFC projection neurons that also
selectively express excitatory or inhibitory opsins. The investigators will test the novel hypothesis that
optogenetic inhibition of this specific neuron ensemble during the cSDS confers resilience, while repeated
activation of these neurons leads to susceptibility to social impairments. Aim 3 will investigate potential
dysregulated gene networks in cSDS-activated mPFC neurons and to what extent such changes depend on
SIRT1, a major human genetic risk factor for depression, through an innovative combination of cSDS in TRAP2
and RiboTag mice and bioinformatics analyses on RNAseq data collected from both male and female mice.
Impact: Successful completion of these aims could reveal a paradigm-shifting practice in circuit-based
therapeutics aimed at restoring prefrontal synaptic homeostasis and could establish a specific corticolimbic
circuit as a lead intervention target for preventing the development of stress induced circuit pathology, which is
otherwise not possible by previous studies examining an indiscriminate wholesale population of PFC neurons.

Public health relevance
PROJECT NARRATIVE (FOR EQUIPMENT SUPPLEMENT) This research is relevant to public health because chronic stress profoundly impacts brain circuit function and is a major risk factor for many neuropsychiatric disorders. In this project the causal role of neural circuits in chronic social stress-induced behavioral impairments in both male and female mice will be studied to provide a mechanistic understanding on social circuit maladaptive changes in response to chronic stress. Successful completion of this study will likely establish a lead neural circuit for targeted interventions to neuropsychiatric diseases featuring social impairments.